FERN Microbiological Cooperative Agreement

FDA FERN Microbiological Cooperative Agreement Continuation Program RFA-FD-12-018 (Reissue of PAR-09-215) PROJECT SUMMARY The Pennsylvania Department of Health Bureau of Laboratories (BOL) will maintain a cooperative agreement with the Food and Drug Administration (FDA) under the FDA FERN Microbiological Cooperative Agreement Program (Program Announcement: RFA-FD-12-018, reissue of PAR-09-215). The BOL will conduct analyses of food and food-related samples to provide expanded laboratory capacity to the Food Emergency Response Network (FERN). FERN will provide samples, instrumentation, test procedures, training and proficiency testing. The BOL will maintain capacity to test a minimum of 100 samples per week and a minimum of 500 samples per year. Testing will be performed for the purposes of surveillance, food emergency outbreak response, and large-scale food emergency event surge capacity.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT The Pennsylvania Department of Health Bureau of Laboratories (BOL) will continue a cooperative agreement with the Food and Drug Administration (FDA) under the FDA FERN Microbiological Cooperative Agreement Program (Program Announcement: RFA-FD-12-018, a reissue of PAR-09-215). The BOL will conduct analyses of food and food-related samples to provide expanded laboratory capacity to the Food Emergency Response Network (FERN). Testing will be performed for the purposes of surveillance, food emergency outbreak response, and large-scale food emergency event surge capacity. __SpecificAimsTextDelimiter__ FDA FERN Microbiological Cooperative Agreement Continuation Program RFA-FD-12-018 (Reissue of PAR-09-215) SPECIFIC AIMS The Pennsylvania Department of Health Bureau of Laboratories (BOL) will maintain a cooperative agreement with the Food and Drug Administration (FDA) under the FDA FERN Microbiological Cooperative Agreement Program (Program Announcement: RFA-FD-12-018, reissue of PAR-09-215). The BOL will conduct analyses of food and food-related samples to provide expanded laboratory capacity to the Food Emergency Response Network (FERN). FERN will provide samples, test procedures, training and proficiency testing. The BOL will maintain capacity to test a minimum of 100 samples per week and a minimum of 500 samples per year. Testing will be performed for the purposes of surveillance, food emergency outbreak response, and large-scale food emergency event surge capacity.